Education and cognitive resilience: what is the role of education characteristics in shaping an ability to maintain high levels of cognitive functioning after the onset of disease

Project Summary
Incident stroke is often accompanied by acute deficits and declines in cognitive ability as well as long-
term acceleration of cognitive decline. These resulting impairments and dementia drastically affect quality of life,
and patients with dementia after stroke are at increased risk of death and disability. Education has been
consistently identified as a predictor of cognition after stroke, but mechanisms behind this relationship are not
fully understood. One hypothesis considers cognitive resilience, suggesting that education provides individuals
with cognitive tools to maintain cognitive functioning amidst a clinically meaningful amount of neurodegeneration
or injury. However, studies of this relationship are hindered by a lack of universally accepted definitions of
cognitive resilience. Furthermore, some studies suggest that the commonly used measure of attained education
may not capture variation in cognition as well as alternative measures such as educational quality and literacy.
The relationship between stroke and dementia has the potential to be used to study cognitive resilience
and reserve, a critical issue in cognitive aging research. By using stroke as a well-defined and clearly diagnosed
disease with a known time of event onset, studies can be conducted to assess for differences between
educational subgroups and to differentiate between normal-age related decline and disease-related pathological
processes. Therefore, this proposal aims to investigate the influence of educational characteristics on
cognitive resilience after stroke. Cognitive resilience will be conceptualized in three distinct ways: cognitive
decline in years following stroke (Aim 1), risk of dementia in patients with history of stroke (Aim 2), and cognitive
testing performance in relation to imaging markers of vascular injury (Aim 3). Analyses will use existing data,
with education measured as self-reported years attained from study participants and state-, year-, and race-
specific measures of educational quality characteristics of average term length, student-to-teacher ratio, and
attendance ratio from historical data from the National Center for Education Statistics. Aim 1 will use a nationally
representative dataset to maximize variation in educational experiences with biennial follow-up surveys to assess
decline after stroke, and Aims 2 and 3 will include members of a large managed care organization with detailed
medical histories throughout adulthood and clinical neuropathologic imaging measures.
This proposal will address the gap in understanding of mechanisms behind the influence of education on
cognitive resilience after stroke. Knowledge from this research will directly address the NIA’s mission of clarifying
understanding of cognitive resilience and reserve, and the priority of understanding determinants of cognitive
aging. The proposed training, guided by an exemplary mentorship team of experts, will enhance the applicants
research competency, content expertise, and rigorous methodological skills needed to advance her career as
an independent academic researcher focused on lifecourse determinants of healthy cognitive aging.

Public health relevance
Project Narrative Dementia is a commonly observed outcome resulting from incident stroke and poses a major public health problem as a determinant of disability and death. Education has been identified as consistent predictor of stroke- related cognition and theorized mechanisms include the concepts of reserve and resilience, however the mechanisms behind this relationship remain poorly understood. This study will use rigorous causal inference methods to add to current knowledge of how education affect cognitive resilience, characterized as cognition after the event of a stroke, to provide new evidence on how characteristics of the educational experience at the individual and state level influence an ability to maintain high levels of cognitive functioning after the event of a stroke.